Regulation of Cortical Progenitor Mitosis

This proposal is to delineate the novel function of apical polarity complex proteins in cortical progenitor mitosis
and uncover a new pathogenic mechanism of microcephaly caused by genetic mutation of Pals1 (protein
associated with Lin7 1, also known as MPP5). PALS1, which has been incriminated only recently as a gene
responsible for microcephaly in humans, encodes a component of the evolutionarily conserved apical polarity
complex. Our multiple Pals1 genetic models using different Cre drivers consistently demonstrate overwhelming
cortical cell loss because of compromised cell viability. However, the cellular and molecular defects behind the
massive cell death found in Pals1 mutants remain unknown. Through extensive time-lapse imaging, we found
that Pals1 loss causes abnormally lengthened mitotic progression, consistent with accumulating evidence that
anomalies of mitosis are a significant cause of microcephaly. Remarkably, analyses of mitotic cells in static
images and time-lapse imaging of Pals1-deficient progenitors revealed the emergence of internalized cells with
nuclei inside of mitotic cells. This unusual cellular behavior mimics entosis, which is cell cannibalism utilized by
tumor cells to engulf live neighboring cells for pro- or anti-tumorigenic purposes. It is unknown whether this
extraordinary cellular event can be pathogenic in other diseases such as microcephaly. Therefore, the mouse
model with an entosis-like process in its cortical progenitors will provide important new insights into the
pathogenic mechanisms of microcephaly. Our preliminary study demonstrated that cell-in-cell (CIC) structures
represent a dynamic and mobile cellular entity that is highly associated with lengthened mitosis and abnormalities
in cytokinesis. As in tumor cells, ROCK inhibition completely abrogates CIC structures and restores the normal
length of mitosis. Furthermore, we detected a striking increase of the P53 target, P21, in the Pals1 mutants and
found that genetic elimination of P53 produces a remarkable rescue of cortical size along with substantial
reductions of CIC structures and cell death. These observations lead us to hypothesize that Pals1 loss
induces CIC pathology responsible for mitotic defects that compromise genomic content and cortical
cell viability through the abnormal activation of Rho-ROCK and p53. To test this, we will determine the
biogenesis, maintenance, and elimination of CIC structures and how they impact mitosis and subsequent
genomic integrity and fate of cortical cells (Aim1). Next, we will study how Pals1 deletion/reduction causes
entosis through abnormal Rho-ROCK activation (Aim2). Finally, we will delineate the effect of P53 activation on
CIC formation and Rho-ROCK regulation in Pals1 mutant progenitors (Aim3). The current study provides an
important molecular and cellular clue as to how Pals1 mutation causes such a dramatic cortical phenotype as
the complete absence of the cerebral cortex and hippocampus. Furthermore, for the first time, our study will
establish that an entosis like process can occur in cortical progenitors, providing a novel pathogenic mechanism
by which entotic cell cannibalism produces microcephaly.

Public health relevance
Microcephaly, and disorder, division abnormal smallness of the head, is caused by genetic mutations, viral infections maternal substance abuse. To prevent or ameliorate this devastating neurodevelopmental the proposal will study pathogenic mechanisms associated with the abnormal cell of neural progenitors.